Screening of US and Jordanian Natural Product Libraries for the Discovery of Blood Brain Barrier (BBB) Penetrant Cathepsin L Inhibitors for the Treatment of Chronic Pain

Project Summary/Abstract
Chronic pain is a debilitating condition that is widely treated with prescription opioid drugs over
extended periods of time. The high prevalence of opioid addiction with abuse and death is now a severe
national crisis in the US. In Jordan, opioid analgesics are highly restricted in their use, and many people
suffer from untreated pain. To address these unmet needs, the goal of this project will be to discover novel
natural products that are potent BBB permeable inhibitors of cathepsin L to produce a lead candidate drug
molecule(s) that reduces spinal dynorphin and attenuates chronic pain without addiction. This goal is
based on compelling evidence showing that spinal dynorphin is a key mediator of chronic pain, and
cathepsin L is largely responsible for the production of dynorphin from its inactive prodynorphin. These
findings support the hypothesis that inhibition of cathepsin L will lead to reduction of dynorphin and
alleviation of chronic pain. An important dimension of this project will be to enrich for BBB permeable
natural products and plant extracts early in the discovery process using an in vitro-parallel artificial
membrane permeability assay (PAMPA-BBB) in a CNS-targeted workflow. For the purpose of screening,
we will choose three distinct sets of natural product extracts and pure compound libraries from various
sources and regional areas, thereby enhancing the diversity in this project. The University of Jordan (JU),
UC San Diego and the NIH-DTP Repository will be subjected for initial screening for their cathepsin L
inhibitory activity at concentrations from 1-10 µg/mL. Active crude extract materials from these
screenings will be subjected to the PAMPA-BBB assay. Permeable eluents and impermeable retentates
from this assay will be evaluated for cathepsin L activity and profiled by LC-MS/MS metabolomics.
Finally, focused/targeted isolation and structure elucidation efforts will be done on fractions that show
several positive selection criteria: promising biochemical activity against cathepsin L, BBB+ in the
PAMPA permeability assay, novel structural features compared to known cathepsin L inhibitors, and a
molecular weight <500. The target fractions will be purified by HPLC, and the pure product structures
will be elucidated using the AI-based tools, Small Molecule Accurate Recognition Technology (SMART)
and DeepSat. The collaborative effort involving the Almaliti laboratory in Jordan and the Gerwick
laboratory in La Jolla offers a remarkable chance to bolster the University of Jordan's staff capabilities
and elevate their expertise in discovering natural products in a region renowned for its historical use of
plants as traditional remedies. These training initiatives in both La Jolla and Jordan will be further
enriched by hosting a natural products symposium in Jordan during the project's second year. Future
collaborations will be established to obtain additional funding and expand this work to other projects in
Jordan and the US.

Public health relevance
Project Narrative The overarching goal of this project is to discover novel natural compounds with the potential to inhibit cathepsin L, thereby reducing dynorphin production and offering relief from chronic pain without the risk of addiction. This research has the potential to present a new approach to addressing chronic pain and addressing the opioid crisis. Moreover, it has the potential to pave the way for the creation of innovative pain treatment alternatives that hold significant value for the healthcare sector in Jordan, especially in a context where the availability of options is extremely limited, hence, addressing unmet medical need.